Endothelial miR-17~92 protects against acute kidney injury

ABSTRACT
Approximately 20% of all hospitalized patients and nearly 50% of critically ill inpatients are estimated to suffer
from acute kidney injury (AKI), which is associated with high rates of morbidity and mortality. While the kidney
may recover, the patients are at a higher risk for subsequently developing chronic kidney disease (CKD); other
times, the acute injury is so severe that there is no kidney recovery. One of the hallmarks of AKI is damage to
the renal microvasculature. This damage alters endothelial function, contributing to hypoxic and inflammatory
injury to the renal parenchyma. Although an angiogenic response (vascular sprouting from existing vessels) is
key to endothelial cell repair (and therefore AKI recovery), the renal microvasculature is thought to have a limited
reparative capacity. There are currently no specific therapies for AKI, nor are there available interventions to
decrease the risk of progression to CKD after AKI. Much of the current interventions are focused on the tubular
epithelium. There are several knowledge gaps that need to be addressed to develop therapies targeted at the
renal microvasculature, including: (1) what are the molecular mechanisms that drive endothelial repair after AKI;
and (2) is it possible to modulate the capacity of the renal microvasculature for repair after AKI?
Our laboratory has previously shown that the miR-17~92 cluster (including the microRNAs (miRNAs): miR-17,
miR-18a, miR-19a/b, miR-20a and miR-92a) is required for normal kidney development and function. This cluster
is known to regulate angiogenesis in other cellular contexts such as tumorigenesis. There is limited information
regarding miRNAs in the renal vasculature in AKI, and the role of miR-17~92 in this context is unknown. Our
team has generated preliminary data following renal ischemia-reperfusion injury (IRI) showing that transgenic
mice lacking miR-17~92 in endothelial cells are more susceptible to renal IRI. Our central hypothesis is that miR-
17~92 promotes endothelial cell repair after injury and protects against AKI; thus making it an exciting therapeutic
target. To test this hypothesis, the following specific aims are proposed: Aim 1- To define the requirement for
endothelial miR-17~92 during renal injury and repair; and Aim 2- To determine whether miR-17~92 is sufficient
to protect against renal injury.

Public health relevance
Project Narrative: ! Together, these studies seek to define the requirement for endothelial-derived miR-17~92 in vascular repair after acute kidney injury. This work has translational relevance, as it establishes the basis for a novel therapeutic approach using members of the miR-17~92 family in the treatment of acute kidney injury. !